Disruption of vocal fold epithelial homeostasis by injury and papillomavirus infection

PROJECT SUMMARY/ABSTRACT
Recurrent respiratory papillomatosis (RRP) is a highly morbid laryngeal disease caused by low-risk human
papillomavirus (HPV) types 6 and 11. RRP is characterized by quickly growing epithelial lesions that impair
voice function. Hoarseness is the most common symptom, resulting in significant communication impairment in
patients with RRP. Available HPV vaccines are preventive only, have low uptakes in the US and globally, and
are given well after RRP arises in children. RRP management involves repeated laryngeal surgery, which can
scar vocal folds and permanently worsen the voice. Risk factors for RRP onset are poorly understood. Most
HPV infections are transient: cleared by the immune system without establishing chronic infection or clinical
disease. The goal of this proposal is to better understand how PV establishes vocal fold infections that lead to
RRP in immunocompetent individuals. One potential avenue is injury. Vocal folds are subject to injury from
multiple mechanical and environmental exposures. PV is thought to enter tissue via a microwound. However,
in the novel in vivo laryngeal mouse papillomavirus (MmuPV1) infection model, laryngeal injury is not required
for chronic laryngeal PV infection and disease in the absence of an immune system. This means that uninjured
vocal fold epithelium permits PV entry. In contrast, in immunocompetent mice, MmuPV1 can only cause vocal
fold disease when epithelium is injured, which indicates that there must be other factors in PV-induced vocal
fold disease establishment besides initial viral entry into epithelium. This proposal will test the overarching
hypothesis that vocal fold injury not only physically facilitates PV entry into epithelium, it also disrupts epithelial
homeostasis and immunity and facilitates increased PV gene expression, such that PV overpowers the ability
of the immune system to control the infection. Aim 1 will use the MmuPV1 laryngeal infection model to define
the extent to which injury enhances PV-induced vocal fold disease in immunocompetent individuals, including
the effect of injury on vocal fold disease in a low-risk HPV milieu that better recapitulates RRP. Aim 2 will use
novel in vivo and in vitro platforms to define the mechanisms by which injury enhances PV-induced vocal fold
disease throughout each phase of the viral life cycle. By better defining how low-risk HPV exploits vocal fold
injury to establish infections that lead to RRP in immunocompetent individuals, completion of the specific aims
will have a significant and sustained impact on laryngology and PV biology. The career development plan
includes advanced virology and molecular biology techniques. Together with clinical training and an extensive
background in laryngeal biology, these new skills will place the candidate in a strong position to work
independently toward her long-term goal to become a clinician-scientist faculty member in academia with a
translational research program that uses well-validated preclinical models to improve mechanistic
understanding of RRP. The University of Wisconsin-Madison is an ideal environment for the K99 phase
evidenced by long-established and active communities and mentors in virology and laryngeal biology.

Public health relevance
PROJECT NARRATIVE Recurrent respiratory papillomatosis (RRP), caused by chronic papillomavirus infection of the larynx, significantly impairs communication and quality of life, but risk factors for chronic infection and disease development are poorly understood. The goal of this proposal is to test the hypothesis that papillomavirus exploits multiple aspects of vocal fold wounding and wound healing to establish disease by using novel immunocompetent mouse models to define the extent to which injury enhances papillomavirus-induced vocal fold disease, and the mechanisms by which it does so. Completion of the specific aims will have a significant and sustained impact on laryngology and papillomavirus biology.